Quantitating Oxytocin-induced Contractility in Bioengineered 3D Human Myometrium

PROJECT SUMMARY
At term (>37 weeks of gestation), the primary function of the uterine myometrium is to produce
forceful contractions to allow delivery of the neonate. Insufficient myometrial contractility during
labor may lead to caesarean delivery; lack of contractility following birth can lead to postpartum
hemorrhage. Therefore, timely and effective myometrial contractility is central to successful
obstetric outcomes. A synthetic form of oxytocin is used to produce forceful myometrial
contractions in ~2million women in the United States. However, oxytocin has a wide therapeutic
index, with women receiving anywhere between 1-40 mU/min, including prolonged exposure
(>24hrs). Both high doses and prolonged oxytocin exposure have adverse maternal and neonatal
outcomes. Our ability to titrate oxytocin dosing is sub-optimal partly due to our insufficient
understanding of the kinetics of myometrial smooth muscle contractility in response to oxytocin.
Current methods of measuring myometrial smooth muscle contractility rely on surrogate collagen
contractility assays that do not directly measure the force from contractile smooth muscle
structures. The measure of contractility of uterine myometrial biospecimens using organ bath
physiology is a gold standard but is limited by an expiry date for ex vivo analyses. Here we
propose to bioengineer an in vitro human 3D myometrium, using patient-derived myometrial
smooth muscle cells. The resulting bioengineered myometrium will resemble a 3D multi-cell layer
thick sheet, with interconnected contractile myometrial smooth muscle cells. Interconnectivity,
contractile phenotype, and genotype of bioengineered 3D myometrium will be benchmarked
against matched patient-derived biospecimens (Aim 1). Importantly, the proposed studies will
directly evaluate the kinetics (amplitude, velocity, and duration) of contraction of bioengineered
myometrium in response to varying doses of oxytocin, benchmarked against similar sized
matched biospecimens (Aim 2). The proposed studies are expected to result in a new method to
directly evaluate myometrial contractility using bioengineered myometrial structures, including
establishing quantifiable metrics for oxytocin-induced contractility. By combining bioengineering
with physiology, we will establish a new starting point for evaluating drugs and management
protocols for labor dysfunction management in patient-derived models of the human uterine
myometrium.

Public health relevance
Oxytocin is widely used in the clinic to induce forceful contractions of the smooth muscle myometrium, yet many pregnant women receive huge variations in doses of oxytocin that portend poor obstetric outcomes. We propose to bioengineer a human 3D myometrium, using contractile myometrial smooth muscle cells, that will be comprehensively benchmarked for form and function against myometrial strips from the same patient. Such patient-derived models are a new starting point to evaluate oxytocin dosing regimens and other uterotonic drugs that can be used in the obstetric clinic.